CORE--BIOMETRICS AND BIOINFORMATICS

The Biometrics and Database Core will assist the project investigators by performing statistical analyses by (1) providing advice on the design and approach to data analysis, and (2) supporting a database that will allow for safe storage of data, a unified approach to data analysis, and the investigation of association between data across the measures performed in various projects.